IMPRINT - Immersive Methods for Promoting Research and Innovations through Novel Training - for Alzheimer's Disease and Related Dementias

IMPRINT for ADRD will consist of two key tracks, combining immersion in the lived experiences
of people affected by Alzheimer’s with training in key aspects of entrepreneurship. Specifically,
the course will include lessons on key elements of biology and pathophysiology, as well as the
social & lifestyle determinants that impact an ADRD patient’s health. It will include an
exploration of novel design solutions, such as a digital phenotyping, as well as data science
tools to elucidate options for earlier detection and prevention. In addition, participants will
observe and potentially engage with patients in their care environments through in-field
ethnography. Entrepreneurship training will provide an immersive, inductive learning approach
to guide participants and teams on the path from ideation to market, including how to define a
problem, methodical approach to solution development. Together, these two tracks combine a
patient-centric, technical, and ethical methods that will help participants develop effective,
inclusive and comprehensive evidence-based interventions and/or treatments to enhance
outcomes for people aﬀected by Alzheimer’s and related dementia diseases.
The program will be built on best practices for healthcare-related innovation and
entrepreneurship. Key components of the program will be led by academic and industry
experts in Alzheimer’s and related dementias, clinical development and evaluation, FDA, legal
and regulatory issues, entrepreneurship, SBIR/STTR grant writing, and more. We will
collaborate with colleagues and programs from UC Berkeley, UC San Francisco, industry,
foundations, memory care centers, and other relevant stakeholders and/or partners.
The pedagogical approach will combine project based learning to foster discovery of solutions
with adult social learning theory (e,g, cooperative learning, building on each subsequent
activity, reinforced by in-ﬁeld interactions with senior care centers and health technology
companies.
Program participants will comprise a cohort of 12-15 graduate students and postdocs from
diverse backgrounds, disciplines, and interests, with a focus on attracting applicants from
underrepresented communities. The IMPRINT program is a one-year, hybrid model, with 15
days of immersive interactive (~12 days at course launch and 5 days at the end) that will cover
team building, site visits, prototyping sessions, and final presentations, combined with weekly
remote sessions (2 hrs/session x 2 sessions/week). Participants will receive a Certificate in
Entrepreneurship & Technology in ADRD upon completion.

Public health relevance
IMPRINT is a one-year immersive learning experience for graduate students and postdocs. The program will enable student par@cipants to translate their knowledge to real-world solu@ons for preven@ng and/or trea@ng Alzheimer’s Disease & Demen@a Related diseases (ADRD) through educa@onal programming that combines immersion in the lived experiences of people aﬀected by Alzheimer’s, with training in key aspects of entrepreneurship. Par@cipants will work in teams to propose and assess poten@al technologies for commercializa@on.